Developmental neuroendocrine toxicity targeting the kisspeptin pathway

PROJECT SUMMARY/ABSTRACT
Atrazine is the second most common agricultural herbicide used in the US and the most frequent agrichemical
contaminant in potable water supplies. Atrazine is regulated by the US EPA at 3 parts per billion (ppb; µg/L) in
drinking water, but concentrations above this regulatory limit are often reported. Laboratory and epidemiology
studies report various endocrine disrupting impacts with most focused along the hypothalamus-pituitary-gonadal
(HPG) axis acting through the suppression of gonadotropin-releasing hormone (GnRH) leading to decreased
luteinizing hormone (LH) release. However, there are several reports on atrazine altering additional endocrine
axes [including adrenal (HPA) and thyroid (HPT)] and neuronal functions and neurobehavior through multiple
neurotransmitter systems (including dopamine and serotonin). A hypothalamic atrazine toxicity target is
hypothesized but is yet to be identified. This target would need to be a master regulator of several hormones
and neuropeptides. We propose the kisspeptin system as this master regulator and will test the CENTRAL
HYPOTHESIS that dysregulation of the kisspeptin pathway by the neuroendocrine toxicant atrazine
connects observed impacts on developmental, reproductive, and neurobehavioral outcomes. Kisspeptin is
responsible for regulating GnRH neurons and subsequent LH release, which is the primary accepted mechanism of
atrazine endocrine disruption along the HPG axis. In addition, kisspeptin modulates the neurotransmitters dopamine
and serotonin regulating multiple neurobehaviors including locomotor and anxiety-related behavior, which are also
reported to be altered by atrazine exposure. Our studies in the zebrafish model system show that an embryonic
atrazine exposure at concentrations around the US EPA regulatory limit in drinking water impacts similar molecular
pathways (neuroendocrine, reproductive, neurotransmission, behavior) through transcript, protein, miRNA, and DNA
methylation analyses; endocrine axes (HPG, HPA, and HPA); neurotransmission systems (serotonin and dopamine);
behavior (locomotor and anxiety-related behavior); and functions (reproductive dysfunction) as identified in humans
and rodent models. The kisspeptin system is also conserved in zebrafish with two kiss genes (kiss1 and kiss2) present
for the mammalian KISS1 gene. The zebrafish presents as an excellent vertebrate model to address the kisspeptin
system, because kiss1 is primarily expressed in the ventral habenula regulating neurotransmission and associated
behavioral outcomes, while kiss2 is expressed in the hypothalamus with neurons projecting to the GnRH neurons.
As such, we can establish genetic mutants with CRISPR-Cas9 technology to investigate the specificity of these two
pathways in aim 1, along with determining the connections with key targets regulated by kisspeptin and altered by
atrazine exposure (e.g., GnRH, LH, dopamine, serotonin). In aim 2, we will then test the hypothesis that atrazine
developmental neurotoxicity on neuroendocrine and neurotransmission pathways is modulated through the
kisspeptin system. This project is novel in significantly advancing our knowledge on the role of kisspeptin as a master
regulator in atrazine toxicity pathways.

Public health relevance
PROJECT NARRATIVE Atrazine is an agricultural herbicide widely used in the Midwestern United States. Atrazine is the most common contaminant of potable water supplies in the United States and is an endocrine disrupting chemical that targets the neuroendocrine and neurotransmitter systems. This study will investigate the kisspeptin system as the master regulator connecting adverse health outcomes observed following developmental atrazine exposure along the multiple endocrines axes and neurotransmission systems for translation to human health risk.